Leveraging Bio-Cultural Mechanisms to Maximize the Impact of Multi-Level Preventable Disease Interventions with Southwest Populations - Admin Supplement

Leveraging Biocultural Mechanisms to Increase the Impact of Multi-level
Preventable Disease Interventions with Southwest Populations
Project Summary/Abstract
The proposed U54 Specialized Center will advance knowledge on how to prevent cardiometabolic disease and
substance abuse disorders among the health disparities populations of the Southwest. The Southwest
Interdisciplinary Research Center (SIRC) has accumulated invaluable expertise in this area for the past 10
years as ASU's Exploratory Center of Excellence (NIMHD/NIH P20MD002316). The stark unmet health needs
of the Southwest communities, the strong transdisciplinary team of researchers assembled for this application,
and the existing solid community partnerships make this application highly significant. The Specialized Center
will leverage SIRC's accumulated knowledge on cultural and social determinants of health and health
disparities and will integrate biological, sociocultural and other contextual factors into efficacious, culturally
grounded and impactful health interventions. We will focus on understanding the protective and risk effects of
interpersonal family and household factors, the community environment, and individual health behaviors on
specific biological health outcomes. The Specialized Center will extend SIRC's integrated, multilevel, social
determinants approach to include biocultural mechanisms within an Ecodevelopmental Theory framework. The
proposed center will significantly enhance SIRC's research impact through a research focus on preventing
cardio metabolic disease and substance abuse disorders through culturally appropriate and efficacious
interventions. The proposed research is innovative because it will investigate how protective and risk factors
that are common to various chronic diseases and disorders manifest themselves among racial/ethnic minority
populations of the Southwest, with an emphasis on the sociocultural and biological determinants of health
disparities. The two proposed main research projects will target potentially modifiable youth behaviors
associated with cardiometabolic disease and with substance abuse disorders (i.e., physical activity, and quality
of diet, access to healthy foods, family functioning, acculturation, substance use, and illegal drug availability).
The resulting findings will inform the design and testing of efficacious interventions that can strengthen
protective factors and counteract risk factors operating within the multiple ecological domains of a young
person's life. The center will conduct the two related main research projects to increase the impact of
efficacious interventions by advancing knowledge on how cultural processes influence biological vulnerabilities
(i.e., biocultural mechanisms). Early career faculty and postdocs will increase their capacity to conduct health
dipartites research through a comprehensive investigator development and pilots research incubator initiative.
The center will implement the research projects and future pilots in close and equitable partnership with
communities of the Southwest. In partnership with the SIRC Community Advisory Board, the center will
broadly disseminate and translate the knowledge generated by the studies and pilots to policy, practice, and
lay stakeholders through an innovative dissemination plan.

Public health relevance
Project Narrative/Public Health Impact Statement Cardiometabolic disease and substance abuse disorders are leading causes of morbidity and mortality among Latinos and other underserved populations in the U.S. Both conditions are preventable but few culturally specific and efficacious prevention interventions exist. The proposed Specialized Center will advance knowledge on how to integrate biocultural processes with social and cultural determinants of health to produce much needed efficacious prevention interventions for youth and their families. Such community-based interventions will have a high positive impact on the health status of Latino youth and other underserved populations of the Southwest and the nation.